GORDON RESEARCH CONFERENCE--BIOENGINEERING &ORTHOPEDICS

The proposed conference will be the Fifth Gordon Research Conference on Bioengineering and Orthopedic Sciences. These conferences are held once in two years and the theme of the Conference will be "Repair of Musculoskeletal Tissues". The conference will have sessions devoted to repair of ligaments and tendons, cartilage and bone. The thrust of the conference will be to discuss the role of isolated growth and differentiation factors on repair and regeneration of skeletal tissues. The objective of the conference will be to: 1) enhance communications among scientists in the fields of cell biology, bioengineering, orthopedic surgery and medicine; 2) to discuss research problems of mutual interest; and 3) foster a mustidisciplinary approach to research in muculoskeletal system and to delineate fruitful avenues for the young scientist in the cutting edges of orthopedic sciences and bioengineering.